Admin Core

Project Summary
The Program entitled “Genetic Variation in Cancer Risk and Outcomes in African Americans” comprises three
Research Projects and two Shared Resource Core components (Administration, and Data Collection and Clinical
Genetics). The Administrative Core provides a common management structure for the Program; i.e., the overall
coordination of all Program-related activities associated with the Research Projects, Cores, the Executive
Committee, the Internal and External Advisory Boards, and the Community Analysis, Results, and Dissemination
(CARD) Board.
Specifically, the Administrative Core will support the Program by integrating various tasks, including 1) providing
leadership and oversight of all Program activities involving Research Projects and the Data Collection and
Clinical Genetics Core; 2) facilitating communication between Program participants, the National Cancer
Institute, and the general public; 3) overseeing fiscal and resource management for each component of the
Program including subcontracts with Duke University, University of Michigan and NorthShore Research Institute;
4) ensuring compliance with all NIH and institutional grant regulations; 5) developing measures to evaluate the
progress and effectiveness of each component of the Program; and 6) soliciting guidance and objective feedback
from the Internal and External Advisory Boards, and the Community Analysis, Results, and Dissemination Board,
and coordinating those meetings.
The Administrative Core contributes to the overall efficiency of the Program by leveraging the existing
administrative infrastructure of KCI, an NCI-designated Comprehensive Cancer Center, the Metropolitan Detroit
Cancer Surveillance System population-based registry, and the Detroit Research on Cancer Survivors (ROCS)
cohort for the successful management of the Program. This strong administrative infrastructure will enable
investigators to fully concentrate on the science of cancer genetics and health disparities.

Public health relevance
Project Narrative The Administrative Core provides the leadership and administrative infrastructure to support Program-related activities, provides fiscal and regulatory oversight, and coordinates mechanisms of feedback, evaluation, and official communication with both the NCI and the community. This Core enables scientists to focus on their research by providing efficient overall management.